Cancer Center Support Grant

PROJECT SUMMARY
Pediatric, adolescent, and young adult (AYA) brain cancer is the most lethal form of childhood cancer,
with limited treatment options. Through national efforts in the last several years, extensive data on molecular
profiles and outcomes of these cancers have been documented, creating a large repository as part of the
Childhood Cancer Data Initiative (CCDI). These data provide a unique opportunity to better understand the
etiology and molecular mechanisms of pediatric and AYA cancers, especially within the brain, and will enable
the identification of new therapeutic avenues. To achieve these results with these public datasets, innovative
tools and approaches are required to take advantage of the incredible resource provided.
Importantly, as these data have been collected, parallel efforts have been underway through the BRAIN
Initiative and other atlas-scale consortia to similarly characterize the cell types that exist in the brain, with a
new focus on the human brain. We have been involved in the creation of atlas scale datasets through the brain
initiative that specifically characterize human brain development. All brain cancers, but especially those that
impact children and AYAs, reactivate cell types and developmental trajectories from normal development. As
such, now is an exceptional time to leverage the existing normal data from the developing human brain and to
integrate it with pediatric and AYA brain cancer data in order to identify what cell types are similar and different,
what gene programs the cancers leverage, and how the cancers interact with normal brain cells to drive their
expansion. Thus, we propose a two pronged approach here to (1) explore characteristics inherent within the
brain cancer transcriptional datasets in the CCDI and to (2) characterize relevant to cell – cell interactions that
could be promoting tumor growth. To do this, we will use novel tools that have enabled us to identify previously
unknown regulators of human brain development to similarly identify core regulators of pediatric and AYA brain
cancer states. With these network based methods, we will also perform robust comparisons between brain
cancers and developmental cell types and states, in the hopes of identifying novel targets that can drive cancer
cell differentiation as opposed to tumor progression. We will additionally apply a novel class of informatic tools
that enable the discovery of cell – cell communication to identify how these pediatric and AYA tumors are
communicating with the rest of the brain; these types of tumor – normal crosstalk have been recently
discovered as key drivers of pediatric brain tumors. This approach may identify additional targets in the
microenvironment that can be addressed therapeutically. Both approaches will provide orthogonal methods of
validating the FDA Relevant Molecular Target List and will provide resources for additional research into these
cancers. As such, all analysis from this project will be shared widely through easily accessible public data
browsers, and we will enthusiastically engage in consortium meetings to share ideas and results.

Public health relevance
PROJECT NARRATIVE Pediatric brain cancers are the most deadly of childhood cancers, and limited treatment options exist. We seek to identify new avenues for treatment by performing analysis of existing pediatric brain tumor datasets using novel approaches that will explore gene networks within these tumors and will interrogate how the tumors communicate with the normal brain around them. Additionally, we will leverage new data generated from the normal, developing human brain to compare and contrast with the tumor data in an effort to more carefully pinpoint how these tumors emerge and what strategies are likely to effectively treat these pediatric brain cancers.